Admin Core

Project Summary / Abstract – Administrative Core
The Administrative Core will serve as the executive, coordinating and oversight component of the Cincinnati
Rheumatic Diseases Resource Center (CRDRC). The Admin Core will provide executive, administrative
(including fiscal), and personnel services to the CRDRC, as well as scientific oversight of the resource cores.
This includes coordination of resources within the Research Cores to enhance ongoing studies and promote
new projects. The Administrative Core will monitor progress and evaluate all aspects of the CRDRC’s operations,
including appropriate expenditures by the Resource Cores and Enrichment Program. The Administrative Core
will prepare required progress reports and regulatory documentation. Leah Kottyan, Ph.D., is the proposed
Director of the CRDRC, and Alexi Grom, M.D. is proposed as Associate Director. Dr. Grom will function as
Medical Director of the CRDRC by providing the liaison to the rheumatology clinic and the fellowship training
program. The CRDCC’s chief executive and administrative body will be a four-member Executive Committee,
which consists of the Director, Associate Director, and leaders of each Research Core. An Advisory Committee
will provide advice to the Director and Executive Committee and will include local and external leaders with
expertise to provide meaningful guidance to CRDRC leadership and Research Core directors. Members will
include individuals experienced in core and center administration who are independent of the CRDRC, but who
are part of, and familiar with, the academic setting within which the CRDRC resides or offer experiences of other
comparable academic centers. Members will include individuals who complement the expertise of and utilize the
Research Cores, and local leaders of programs that synergistically interact with the CRDRC. An Enrichment
Program will be offered that includes research seminars, education relevant to technologies of the resource
cores, and strategic planning of research goals. A novel and innovative P&F Program is proposed and will be
managed by the Administrative Core to extend impact of Center resources to a larger number of investigators.
This program will focus on advancing utilization of CRDRC cores or institutional cores to provide access to key
technologies that might otherwise be cost-prohibitive. Projects will be solicited from the research community and
the larger academic health center. A P&F Study Committee will assist in the selection of new P&F Studies and
monitor progress of ongoing P&F Studies. This program will provide a valuable mechanism for advancing new
investigators and new projects in the field of pediatric rheumatology. A Visiting Scholars program will fund travel
grants to bring trainees and faculty underrepresented in medical research to Cincinnati to learn from our
Resource Cores. These grants are intended to provide opportunity and training while expanding the diversity of
future research trainees, physicians, and faculty in the Research Community. In summary, the Administrative
Core will enable the success and create fertile ground for accomplishing the overall goals of the CRDRC.